EchoMRI

PROJECT SUMMARY/ABSTRACT
This application requests funds to purchase the EchoMRI-3in1™ whole body and tissue composition
analyzer, a critical tool to support the analysis and interpretation of metabolic data generated from the
Comprehensive Laboratory Animal Monitoring System (CLAMS) in the Brigham and Women's (BWH)
Metabolic Core. There is an urgency to understand the origins and consequences of metabolic dysfunction,
which is at the forefront of many diseases, including diabetes, obesity, cardiovascular, immunological, and
neurological diseases. Alterations in body composition, systemic thermogenesis, metabolic rate, macronutrient
utilization, food intake, and physical activity underpins homeostatic and pathophysiological metabolic states.
Current BWH Metabolic Core researchers who utilize the CLAMS and other core services have successfully
identified mechanisms of metabolic dysfunction in a variety of genetically modified mouse models, in response
to dietary interventions and in a broad spectrum of research fields, including immunology, cardiology,
gastroenterology, and endocrinology. The use of the EchoMRI is just as equally needed for the numerous
investigators that require body composition analysis to interpret data related to adiposity and lean mass.
The CLAMS is the gold standard in metabolic research for assessing systemic metabolism; however, a
significant analytical challenge to the interpretation of CLAMS data is an appropriate normalization for body
weight. The contribution of fat mass versus lean mass to thermogenesis is significantly different; therefore,
including a highly variable fat mass when normalizing a mass-dependent metabolic parameter to whole body
weight can confound estimates of thermogenesis. This approach has led to the misidentification of aberrant
metabolic phenotypes. The metabolic field is making a substantial effort to address this issue by bringing
attention to the necessity of normalizing metabolic parameters to lean mass and account for fat mass. The
EchoMRI measures precise body composition of fat, lean, free water, and total water masses in a rapid, non-
invasive manner and can measure organs and tissue samples of up to 7 grams and biopsy samples of up to
0.3 grams. Procurement of the EchoMRI will fulfill a critical much-needed component to complement the 24
CLAMS cages currently in operation in the Metabolic Core. Analyzing CLAMS metabolic data without whole-
body composition can limit data interpretation and impede more robust and thorough conclusions. The
EchoMRI can and will be used independently of CLAMS experiments.

Public health relevance
PROJECT NARRATIVE The amount of body fat, lean mass, and water in an organism, also known as body composition, is critical to understanding the causes and consequences of metabolic dysfunction. Metabolic dysfunction is a key component numerous highly prevalent disorders, including obesity, diabetes, cardiovascular dysfunction, immunology disorders, cancer, and neurological diseases. This application requests funds to purchase an EchoMR™, a high-precision tool that will advance the metabolic research of investigators of the BWH Metabolic Core.